Identifying novel trunk reflexes and their differences after neonatal versus adult spinal cord injury

Project Summary / Abstract
A highly compelling observation in spinal cord injury (SCI) is that in neonatal complete spinal transection at
thoracic levels in cats, rats and mice, a fraction of the injured individuals develop variations of useful quadrupedal
weight-supported locomotion as adults, although after complete spinal transection in adult animals there is no
useful recovery. In rats the fraction of individuals that show integrated quadrupedal weight support, using the
hindlimbs is about 20%. Understanding how this level of function is developed after neonatal spinal complete
injury and maintained in adults may be an important signpost to new therapies applicable in clinic.
We and others have published data indicating that trunk control is crucial to the useful quadrupedal weight-
supported locomotion of neonatal injured rats. New data in our group suggested some previously undescribed
monosynaptic contralateral reflex pathways in the rat trunk. These reflexes couple muscles across the midline
with rapid reflexes. Other published data shows that alteration in trunk motoneuron structure in early neonate
SCI which might alter these newly discovered pathways, which would impact trunk control. This speculated
difference might be among mechanisms that support the unusually good recovery of quadrupedal function after
neonatal SCI. Our goals in the proposed project are to test if the trunk reflex patterns seen in adult animals are
altered after spinal cord injury, focusing on the novel contralateral monosynaptic pathways. We hypothesize that
after neonatal SCI the novel contralateral monosynaptic pathways are lost. We test this with two Specific Aims,
the first examining the hypothesis using anatomical tracing, and the second using electrophysiological reflex
testing. The significance of the project is that the data to be obtained will lead to better understanding of elements
of trunk motor function, and recovery of trunk motor function after SCI. The data will determine future directions
of research in neonatal and adult SCI in rodent models. Trunk control and recovery of effective trunk control is a
crucial aspect of the restoration and recovery of motor function after both adult, juvenile and neonatal SCI.
Depending on the results, the project data may lead to the design of new therapies and tests in rodents, with
potential for translation to clinic.

Public health relevance
Narrative Trunk control and recovery of effective trunk control is a crucial aspect of the restoration and recovery of motor function after both adult, juvenile and neonatal spinal cord injury (SCI). The project examines reflex trunk control after neonatal SCI, when recovery of function is much better than in adult SCI. This study is expected to shed light on trunk control changes after SCI in the rodent model used, and this may lead to insights useful for new rehabilitation strategies and therapies.